Axon selection for myelination by excitatory postsynaptic factors

PROJECT SUMMARY
Myelin, produced by oligodendrocytes (OLs), is a specialized lipid-rich membrane critical for rapid electrical
signal transmission in the central nervous system. OLs are uniquely positioned to modulate circuit activity as
they can myelinate up to 40 axons simultaneously, while also differentially distributing myelin on individual
axons. Yet how oligodendrocytes select axons for myelination has only recently started to be explored. Our lab
has shown that neuronal activity promotes and stabilizes myelin sheath formation and that synaptic vesicle
release occurs along axons underlying nascent myelin sheaths. Together, this suggests an intricate
mechanism of communication, where oligodendrocytes receive myelination promoting signals from axons.
Interestingly, we have found that in OLs, postsynaptic scaffolding and adhesion proteins occupy nascent
sheaths and regulate myelin sheath characteristics. Most recently, work from our lab has shown that OLs use
specific postsynaptic proteins to myelinate axons based on their neurotransmitter identity. Specifically, we
found that the canonical postsynaptic scaffolding protein Gephyrin is enriched in myelin of inhibitory
GABAergic and glycinergic axons, functioning to select and regulate the distribution of myelin to these axon
classes. If inhibitory postsynaptic proteins guide the myelination of inhibitory axons, do excitatory postsynaptic
proteins guide the myelination of excitatory neurons? I hypothesize that the excitatory postsynaptic protein
PSD-95 regulates the myelination of glutamatergic neurons by coordinating localization of adhesion molecules.
In this proposal, I will utilize genetic manipulation and in vivo and fixed light microscopy in zebrafish to test this
hypothesis via two aims. Aim 1 tests if the canonical excitatory scaffolding protein PSD-95 selects and
coordinates myelin distribution on glutamatergic axons. Aim 2 tests if PSD-95 regulates myelination by
coordinating the localization of excitatory postsynaptic cell adhesion molecules.

Public health relevance
PROJECT NARRATIVE Axon myelination plays a vital role in neural circuits by modulating action potential speed, and abnormalities in myelin can lead to white matter deficiencies and cognitive impairments observed in many neurodevelopmental disorders. Despite this link, the developmental process of axon selection for myelination remains poorly understood. This research aims to determine whether oligodendrocytes employ synaptic-like mechanisms to select specific axons for myelination, particularly if the excitatory scaffolding protein PSD-95 coordinates postsynaptic adhesion molecules to facilitate myelination of glutamatergic axons.